Next-generation phenotypic antimicrobial susceptibility test platform: rapid resultsand comprehensive menus

The goal of this CRP SBIR proposal is to fund four projects to advance the commercial
readiness of Selux’s rapid, comprehensive, low-cost, phenotypic antibiotic susceptibility
test (AST) system. Selux’s next-generation phenotyping (NGP) platform uniquely enables rapid
AST with comprehensive antimicrobial menus of >50 drugs at a low cost from isolates and
positive blood culture samples. Aims 1 and 2 focus on cost reduction projects important for early
customer adoption. Aim 1 comprises analytical studies to support multiplex oral panels and Aim
2 is a DFM redesign of the Analyzer consumable pack. Aims 3 and 4 focuses on work
necessary for later customer adoption. Aim 3 is a yearlong benchmarking study that will
compare Selux NGP performance against legacy AST systems and reference methods. By
improving system workflows and benchmarking AST performance across legacy systems CRP
funding will help position Selux NGP as the dominant AST platform of the future.

Public health relevance
The new paradigm in clinical medicine is value-based healthcare, which requires rapid and accurate diagnoses leading to optimal patient treatment. Nowhere is this more important than in treating infections, where doctors are currently forced to overprescribe broad-spectrum antibiotics during an agonizing 2-4 day wait for antimicrobial susceptibility test (AST) results. This proposal will advance the commercial readiness of Selux’s novel AST platform, which uniquely enables rapid AST with comprehensive test menus. This advance would be transformative for the treatment of infections because the current over-use of broad-spectrum antimicrobials not only harms individual patients but is a primary contributor to the growing epidemic of antimicrobial resistance.